HEPATIC GLUCONEOGENESIS IN NORMAL, NIDDM, AND CIRRHOSIS PATIENTS

This protocol will investigate defects in glucose (blood sugar) metabolism in patients with diabetes mellitus and liver disease. Hopefully, the results of this study will provide a better understanding of the way the tissues of normal people metabolize glucose and what goes wrong in patients with diabetes and liver disease.